Immunometabolic regulation of enteric viral infection

Project Summary/Abstract
Obesity is a global health concern as it is a risk factor for several of the leading causes of death such as heart
disease, kidney disease, and type 2 diabetes. Obesity drives dysregulated inflammation, which has been
shown to be a risk factor for increased morbidity and mortality in certain pulmonary viral infections such as
influenza A and SARS-CoV-2. Yet it is unknown how diet induced obesity (DIO)-associated inflammation
impacts the immune response to viruses that infect the gastrointestinal tract. It has been well-established that
DIO drives dynamic changes in intestinal immunity, including alterations in interferon gamma and IgA
production. Specifically, DIO induces skewing towards type I immunity, which is protective against intracellular
pathogens like viruses. Norovirus (NV) is one of the most prevalent gut viruses, as it is the number one cause
of acute viral gastroenteritis worldwide. However, the effects of DIO induced type 1, or anti-viral, skewing on
immunity to NV have yet to be elucidated.
My new preliminary data indicate that mice placed on a high fat diet (HFD) prior to infection with persistent
murine NV (MNV) strain CR6 clear the infection in just 28 days, while mice fed normal chow (NC) remain
persistently infected. This clearance appears to be independent of MNV receptor expression and viral tropism.
Additionally, we found that obese patients with symptoms of gastroenteritis are less likely to test positive for NV
than symptomatic lean controls, which further supports our mouse model indicating a HFD is protective against
NV infection in both mice and humans. We also observe changes in the humoral response to MNV in our
mouse model, as HFD-fed mice have an increase in serum MNV specific IgG and decrease in both serum and
secretory MNV specific IgA in comparison to infected mice on NC. These findings lead to my central
hypothesis that obesity drives alterations in intestinal immunity that promote an anti-viral state and
protect against norovirus infection. I have proposed two aims to address this hypothesis. In Aim 1, I will
elucidate the role of DIO-mediated changes in B and T cell responses in protection against MNV infection. In
Aim 2, I will determine the role of interferon signaling in DIO-associated clearance of MNV. This novel work will
advance our understanding of the relationship between diet and immunity to NV infection. This work also has
translational potential as it may provide insight to treatment for NV, as there is currently no vaccine for this
common virus.

Public health relevance
Project Narrative Obesity is associated with worse morbidity and mortality of pulmonary viral infections like SARS-CoV-2, however the effects of obesity on intestinal viral infections, specifically norovirus, remains poorly understood. My new preliminary data reveal that human and murine obesity are associated with protection from norovirus infection in association with enhanced norovirus-specific antibody production. In this proposal, I will determine how the adaptive immune response (Aim 1) and interferon signaling (Aim 2) mediate protection against norovirus infection in high fat diet-induced obese mice.